STUDIES OF REGIONAL ADIPOSE TISSUE FATTY ACID STORAGE IN HUMANS

These pilot studies are designed to test a new model of predicting the storage on meal fat and VLDL fatty acids in intra-abdominal adipose tissue.